Schlemm’s canal targeted-Tie2 knockdown as a mouse model of adult-onset ocular hypertension and glaucoma

Glaucoma causes irreversible vision loss and blindness, but we still lack understanding of the multipart
mechanisms that cause and drive glaucoma progression. Animal models enable investigation of cellular and
molecular players throughout disease, and are essential for testing and optimizing new treatments. There is a
need for animal models that selectively model pathogenic events of human glaucoma to trigger
neurodegeneration with a predictable time of onset and progression. We have developed a mouse model that
selectively disrupts Schlemm’s canal (SC) expression of Tie2, which is associated with ocular hypertension
and glaucoma in humans. The studies proposed here will define the timecourse, sequence and variability of
functional and structural optic nerve and RGC neurodegeneration in this model. We will also develop a
CRISPR/Cas9 approach to disrupt Tie2 expression in SC, which could be applied independent of genetic
background. This project is expected to provide an inducible glaucoma model relevant to study the
pathogenesis of ocular hypertension and neurodegeneration, and a preclinical tool to evaluate new treatments
for human glaucoma.

Public health relevance
Glaucoma causes irreversible vision loss and blindness, but treatments remain limited. There is a need for animal models, ideally those based on mechanisms of human disease, to investigate pathways involved in glaucoma progression and to test new treatments. Here we propose to develop a rodent model of glaucoma that will be relevant to study the pathogenesis of ocular hypertension and neurodegeneration in glaucoma.